Priming with High-Frequency Trans-spinal Stimulation to Augment Locomotor Training Benefits in Spinal Cord Injury

PROJECT SUMMARY
Spinal cord injury (SCI) greatly impairs standing and walking ability, which severely compromises daily living
activities. While these deficits are partially improved by locomotor training, even after multiple training
sessions, abnormal muscle activity and coordination still persist. Thus, locomotor training alone cannot fully
optimize the neuronal plasticity required to strengthen the synapses connecting the brain, spinal cord, and
local circuits. As such, treatment interventions that effectively promote neuromodulation of spinal locomotor
networks and strengthen neural connectivity of the injured human spinal cord are greatly needed.
Transcutaneous spinal cord (transspinal) stimulation alters motoneuron excitability over multiple segments by
bringing motoneurons closer to threshold, a pre-requisite for functioning descending and local inputs.
Importantly, whether concurrent treatment with transspinal stimulation and locomotor training maximizes motor
recovery after SCI is unknown. The goal of this clinical trial is to use high frequency (30 Hz) transspinal
stimulation to prime locomotor training and ultimately improve standing and walking ability in individuals with
chronic incomplete SCI (iSCI). Forty-five individuals with iSCI will undergo 40 sessions of body weight-
supported step training primed with high-frequency transspinal stimulation. Participants will be randomized to
receive transspinal stimulation during standing (real or sham) or while supine (real). Aim 1 evaluates how
priming locomotor training with high-frequency transspinal stimulation in iSCI alters corticomotoneuronal
connectivity strength, as indicated by motor evoked potentials recorded from the legs. Aim 2 evaluates how
priming locomotor training with high-frequency transspinal stimulation in iSCI affects reorganization and
appropriate engagement of spinal neuronal circuits. Finally, Aim 3 evaluates improvement in intralimb
coordination and the ability to stand and walk. These results will support the notion that tonic high-frequency
transspinal stimulation strengthens corticomotoneuronal connectivity through posture-dependent corticospinal
neuroplasticity. Additionally, these results will indicate appropriate neuromodulation and facilitation of spinal
locomotor neuronal networks. We anticipate that the information gained from this mechanistic clinical trial will
greatly impact clinical practice. This is because in real-world clinical settings, noninvasive transspinal
stimulation can be more easily and widely implemented than invasive epidural stimulation. Additionally, by
applying multiple interventions to accelerate motor recovery, we are employing a treatment regimen that
represents a true clinical approach. Indeed, this multi-faceted approach meets the priorities of the National
Institutes of Health for rehabilitation.

Public health relevance
We lack specific knowledge on the benefits of concomitant utilization of multiple therapeutic interventions after SCI in humans. We will use comprehensive neurophysiological and clinical approaches to investigate recovery of standing and walking when transspinal stimulation primes locomotor training in persons with SCI. This work will have a great impact on clinical practice and may change the standard of care.